The cis-regulatory grammar and epigenetic control of human interneuron progenitor specification

Control of gene expression involves interactions between genomic cis-regulatory elements (CREs) and the
transcription factors that bind them, while chromatin modifiers also modulate genome access to control cell
type specification during development. Defining these regulatory controls is important, as most human genetic
variation linked to disease is in non-protein coding sequences, but the locations and functionality of CREs that
specify many developing human cell types has not yet been defined. In the cerebral cortex, balanced
development of inhibitory cortical interneurons (cINs) and excitatory neurons (cEXs) is required for proper
function. cIN development is susceptible to perturbation to cause multiple neurodevelopmental disorders
(NDDs), while NDD contributory mutations are found in many genes encoding chromatin modifiers, linking
disrupted epigenetic regulation of cIN development to NDD etiology. However, most aspects of molecular
regulation of human cIN development remain undefined, including which regulators are required, the CREs
through which these regulators act and networks of gene expression under their control, effects of their
disruption on cIN development, and contributions of human mutations in these genes and CREs to NDDs. To
elucidate these, we use a directed differentiation model that mimics many aspects of human cIN specification
and differentiation, is robust and experimentally manipulable, and has high utility for studying these processes.
Here, we begin to define the central regulatory logic underlying the cIN developmental program and build a
foundation for studying how its disruption contributes to NDD etiology. We first integrate several types of
genome-wide data to define putative CREs controlling cIN specification. These data will be used to assess how
pathogenic mutations in both CREs and in genes encoding chromatin modifiers disrupt cIN development to
cause NDDs. We next explore roles for CHD2, a gene encoding a chromatin remodeler mutated to cause
several NDDs: we define direct targets of CHD2 regulation, their dysregulation in the context of different
pathogenic CHD2 gene variants, the epigenetic mechanisms involved, and effects of these CHD2 pathogenic
mutations on development and function of cINs and cEXs. This work will elucidate both CHD2's required roles
and mechanisms in cIN development and the basis of their disruption in NDDs. Finally, we conduct massively
parallel reporter analysis: high throughput, quantitative, CRE activity testing is used to identify bona fide
functional CREs, define cis-sequence requirements for CRE regulation during cIN specification, and compare
CRE activity in cIN versus cEX progenitors and with single or combinatorial transcription factor binding site
mutation. A subset of these CREs is then validated by epigenome editing. Together, this work will elucidate the
cis-regulatory logic of a human cell type-specific gene regulatory program central to neurodevelopment and
disease, while building a resource and experimental foundation for further dissection of how pathogenic
variants both in human coding and non-coding genome sequences disrupt this program, contributing to NDDs.

Public health relevance
This work will define mechanisms that control gene expression to drive the development of human cortical interneurons. Mutations in the human genome sequence frequently disrupt these gene regulatory controls, perturbing interneuron development and contributing to disorders of the developing nervous system, such as pediatric epilepsies and autism spectrum and intellectual disability disorders. Many aspects of regulation of this developmental program appear to be unique to humans, and human genome sequence variants that cause disease are also often not present in other species. Therefore, modeling how this human neurodevelopmental program is regulated is necessary to build a foundation and resources for determining how such human- specific mutations disrupt this regulation to contribute to neurodevelopmental disorders.